Piloting a Novel Approach for Examining Intersecting Environmental Exposures and Social Behavior

Project Summary/Abstract
Rates of neurodevelopmental disorders (NDDs) are rapidly and inexplicably rising with one in six US children
aged 3-17 diagnosed with a developmental disability between 2009 and 2017, and nearly 33% of US children
aged 13-18 suffering from an anxiety disorder. Mental health disorders such as anxiety and autism spectrum
disorder (ASD) manifest in each sex differently and can persist for a lifetime, thus understanding their origins is
highly significant. Prenatal exposure to chemical pollutants such as air pollution, plasticizers, and flame
retardants (FRs), are hypothesized to be one causal factor elevating NDD risk in both sexes. The available
experimental data, however, testing this hypothesis is surprisingly minimal and discordant. Moreover, chemical
exposures frequently occur in combination with other stressors known to heighten risk of psychosocial disorders
including chronic stress and social isolation. Thus, understanding how multiple adverse environmental “hits” act
in combination to exacerbate risk of socioemotional deficits is a critically important but unmet need. This project
addresses the pressing need for rigorous, reproducible, human-relevant studies examining potential links
between environmental exposures and social deficits common to many NDDs.
We will use the prairie vole (Microtus ochrogaster), a well-established, pro-social animal model for
exploring the neurobiology of ASD and other social disorders, but generally unfamiliar to toxicologists,
to test the hypothesis that father absence during rearing will exacerbate known behavioral deficits
induced by developmental exposure to the chemical flame retardant (FR) mixture FireMaster 550, (FM
550) particularly in male offspring. Unlike rats and mice, this species is monogamous and biparental and thus
a uniquely suitable model for examining the impact of adverse events on social behavior. Our preliminary data
in FM 550 exposed prairie voles reveal heightened anxiety in females and loss of pair bonding in males. The
focus on FRs is significant because exposure to this chemical class has long been associated with behavioral
and cognitive impairments in humans, including heightened risk of ASD, and human exposure is global and
increasing. The proposed self-contained study builds on our prior work by using oral exposure to a human
relevant dose, more refined testing strategies to better capture pair bonding behaviors, and the inclusion of father
absence as a second adverse childhood exposure; a situation all too common in heavily polluted communities.
This innovative, feasibility study is highly responsive to NIH interest in the “exposome” (chemical and
experiential) as a driver of children's health. Through this small, defined project we hope to elucidate the impact
of combined early life stressors on social traits of relevance to human NDDs in both sexes. Critically, the
behavioral results gained from piloting the prairie vole as a powerful tool for toxicology paves the way for future
work seeking to identify the mechanisms by which chemical exposures may contribute to the growing prevalence
of NDDs in the context of the full exposome.

Public health relevance
Project Narrative Rapidly rising rates of neurodevelopmental disorders, including autism and anxiety, have a strong sex bias and significant social deficits. Environmental stressors, including chemical exposures are strongly suspected causal factors but the capacity to assess their individual and combined impacts on sociality in traditional lab animals is limited because those species are not prosocial; thus here we will use a monogamous, biparental species to examine the sex-specific impact of a flame retardant mixture shown to impair complex behaviors in rats, on prosocial behavior including pair bonding. Developmental exposure will occur alone or in combination with postnatal social stress (father absence) to model the human reality that polluted communities face myriad early life adversity.